Neural circuits mediating food impulsive behavior

Project Summary/Abstract
Impulsivity is implicated in many neuropsychiatric disorders1 and food-directed impulsivity is
associated with both obesity and binge-eating disorder2–4. Impulsive behaviors can be roughly divided into two
distinct subtypes: behaviors resulting from a failure to suppress an inappropriate action (impulsive action) and
behaviors wherein a choice between two or more responses is made without proper consideration of the
consequences (impulsive choice). While the neural processes regulating impulsive responding are poorly
understood, evidence exists that impulsive actions and impulsive choices may be modulated by both
overlapping and distinct neural substrates5. The hippocampus (HPC), a brain region crucial for mnemonic
function, has recently been identified as a critical region mediating the higher-order control of appetite and
food intake6,7 . Our recent findings have further shown that the ventral subregion of the HPC (vHPC) plays a
critical role in mediating impulsivity directed towards palatable food8,9. However, the neural processes and
circuitry through which the vHPC modulates impulsive responding for palatable foods remain unknown.
In addition to the vHPC, The nucleus accumbens (ACB) is also known to regulate impulsivity10–13, and
ACB-projecting hippocampal neurons have been shown to enhance food palatability14. Deep brain stimulation
(DBS) of the ACB shell subregion (ACBsh) increases impulsive responding in rats15, and a pilot study of
responsive DBS in the ACB for patients with BED improved lose-of-control eating frequency and was
associated with weight-loss16. Previous research on HPC-to-ACB circuitry has focused its role in
neuropsychiatric disorders17 and on non-food related reward processing, such as drugs of abuse18,19. Despite
both the HPC and ACB being implicated in food-motivated behavior and impulsivity, it is unknown whether
HPC-to-ACB communication modulates behavioral inhibition for food-motivated responding.
We hypothesize that the vHPC regulates impulsivity for palatable foods via downstream connections to
ACBsh. Preliminary data presented herein reveal increased calcium-dependent activity in both the vHPC and
ACBsh in rats immediately prior to a non-impulsive relative to an impulsive lever press. Aim 1 experiments
build off these findings by using pathway-specific in vivo fiber photometry to record calcium-dependent
activity in the ACBsh-projecting vHPC neurons during impulsive responding. Our preliminary findings further
show that chemogenetic vHPC-to-ACBsh inhibition increases impulsive action for palatable foods in males.
Aim 2 will build on these findings by exploring the effects of pathway-specific inhibition on impulsive action in
females, as well as impulsive choice in both males and females. Finally, Aim 3 uses multi-synaptic neural
pathway tracing and in situ hybridization to identify the neurochemical phenotype and downstream targets of
the vHPC-to-ACBsh pathway. Overall, improved understanding of the neurobiology underlying food-directed
impulsivity can shed greater light on the role of food motivation and behavioral inhibition in obesity.

Public health relevance
Project Narrative Over 40% of American adults are obese and due to a lack of effective and affordable treatments for weight loss, the obesity epidemic remains a public health crisis. One hypothesis about the etiology of the obesity epidemic is that obesity is associated with increased reward sensitivity, coupled with increased impulsivity which drives excessive food intake. Here, we investigate how a ventral hippocampus to nucleus accumbens shell pathway regulates impulsive responding for palatable foods in order to provide basic science insight into the etiology of obesity.